Thalamic regulation of prefrontal dynamics in decision making under uncertainty

Abstract:
Research Plan: Decision making is a process through which actions are selected based on sensory cues or
value of desired outcome. Critical to their function decision making systems, like the prefrontal cortex (PFC),
need to capture the causal structure of its environment (an internal model or belief system) and update its
internal beliefs when underlying associations change.
While a lot of effort has gone into understanding neural circuit mechanisms within the PFC recent findings
suggest that interactions with the medio dorsal thalamus (MD) is crucial for its function and are especially
important when decisions must be made using information that is noisy. Moreover, failure to resolve noise in
updating internal beliefs is thought to underlie schizophrenia and related psychotic illnesses. Thus,
determining the circuit mechanisms of MD-PFC interactions is relevant to not only cognitive neuroscience but
also to psychiatry. This K99/R00 research proposal will address the role of MD in regulating PFC dynamics
during decision making under uncertainty through the following three Aims. Aim 1, will explore if genetically
identifiable populations within the MD, due to their unique connectivity with the PFC, are selectively geared
towards resolving sensory input uncertainty arising from high noise versus low signal. Aim 2 will explore the
role of MD in a multi-step decision making paradigm to study human-like reasoning using treeshrews (Tupaia),
which are akin to basal primates. The first two Aims 2 will be carried out in the K99 training phase. In Aim 3,
performed in the independent R00 phase the findings from Aim 1 and 2 will be extended to economic decision
making where uncertainty exists at the level of expected rewards. These Aims collectively, will elucidate the
circuit mechanisms through which the MD-PFC interactions play a role in resolving uncertainty in decisions
and will further provide precise targets through which deficits in decision making can be therapeutically
ameliorated.
Career Development Plan: The K99 training will provide the tools and training necessary to study the activity
of neurons in the brain to decipher underlying circuit mechanisms. The R00 phase will build the foundations
of an independent research career driven by experiments that deconstructs complex decision making into a
combination of simpler cognitive processes sub served by specified circuitry.

Public health relevance
Public Health Relevance Statement This project explores how uncertainty in our environment and predictions are resolved through direct communication between the thalamus and the prefrontal cortex. Additionally, it will set the stage for future translational studies for psychiatric disorders that present with atypical handling of uncertainty.